Xenbase - Admin Core

Component: ADMINISTRATIVE CORE
PROJECT SUMMARY/ABSTRACT
Xenbase is a Multi-PI and Multi-Site collaborative project between Dr. Aaron Zorn, who
manages the Curation team at Cincinnati Children’s Hospital, and Dr. Peter Vize, who manages
the knowledgebase and software development team at the University of Calgary, Canada.
The function of the Administrative (Admin) Core is to provide the administrative and
organizational infrastructure necessary to implement the Multi-PI Management Plan and to
maintain efficient operations. The Admin Core monitors progress of each component and is
responsible for reporting to the Xenopus community, the External Advisory Board (EAB) and the
NIH. The Admin Core provides coordination and communication between the Calgary and
CCHMC teams, their internal administrations, as well as with external resources. Finally, the
Admin Core is responsible for financial management and ensuring that the budget of each
component is used appropriately and effectively.
Aim 1: To provide the administrative and organizational infrastructure necessary to implement
our Multi-PI plan and to maintain effective operations.
Aim 2: To promote coordination and communication between the Technology Development and
Curation teams, and to facilitate integration of the different components of the project.
Aim 3: To provide mechanisms for oversight and reporting to the Xenopus community, the
External Advisory Board (EAB) and the NIH.
Aim 4: To facilitate interactions between the Xenbase leadership and the leadership of other
MOKs, Stock Centers, and external resources such as the NCBI.